Community Engagement Core

PROJECT SUMMARY (Community Engagement Core: Chief, Rainie, Maier)
The University of Arizona (UA) Superfund Research Program (SRP) has successfully translated research
findings focused on the health and environmental impacts of mining on vulnerable communities and engaged
affected citizens to reduce and mitigate exposure through learning modules, outreach activities, workshops,
capacity building, and developing community engaged participatory research. The UA SRP Community
Engagement Core (CEC) will continue to engage Native American communities and Tribal Colleges and
Universities in the Southwest that are located adjacent to mining sites by building and expanding upon previously
nurtured partnerships including The Tohono O’odham Nation, Tohono O’odham Community College, The Navajo
Nation, Diné College, and Navajo Community Health Representatives. The goal of the current UA SRP CEC is
to specifically focus on community engagement with Native Americans living near mining sites, as these
communities are disproportionately impacted by mining and arsenic contaminated water, resulting in increased
exposure to arsenic and higher rates of diabetes, particularly uncontrolled diabetes. Supported by the Data
Management and Analysis Core and the Administration Core and working in close coordination with the
Research Experience and Training Coordination Core, the CEC will ensure community-engaged participatory
research, training, education and capacity building through the development of community-engaged tools
centered around a solution-based approach to indigenous food sovereignty as a means to minimize and mitigate
the increased risk of diabetes. Food sovereignty efforts are developing and exist in many tribal communities,
however, the connection to arsenic in water as a result of mining and increased risks to diabetes is lacking. Using
findings from the UA SRP research projects, the CEC will engage in multi-lateral communications with key
stakeholders. Specifically, the CEC will be instrumental in innovatively engaging tribal communities in a manner
that takes cultural values and traditions into consideration (in an indigenous-centric manner) and will provide
training, education and capacity building to maintain food sovereignty and decrease the risks of arsenic
exposure. By empowering tribal communities to take local action to mitigate and minimize these impacts in a
more sustained manner, the approach of the UA SRP CEC will be truly bilateral. Finally, the UA SRP CEC will
engage tribal partners in the research process to increase understanding of environmental and health risks of
mining and arsenic contaminated waters that lead to increased risks to diabetes. Most critically, the CEC will
engage in mitigation approaches to reduce and minimize risks to vulnerable Native American populations.
Engagement with tribal communities will increase awareness of risks and best practices in ways that honor tribal
sovereignty and knowledge and aid in cultural understanding while reducing racial misconceptions and fostering
university-community partnerships based on trust and transparency.

Public health relevance
PROJECT NARRATIVE (Community Engagement Core: Chief, Rainie, Maier) The University of Arizona Superfund Research Program (UA SRP) Community Engagement Core (CEC) will utilize community-based participatory research to address increased exposure to arsenic and the impact of exposure on metabolic diseases, particularly diabetes risk, in Native American communities living near mining sites. Recent evidence suggests that Native American communities are disproportionately impacted by mining and arsenic contaminated water, resulting in increased rates of diabetes in Native Americans. The tools developed by the UA SRP CEC will be used for multi-lateral communications with Native American communities to enable these vulnerable populations to make informed decisions on health issues related to mining, arsenic contamination, and remediation efforts.